A new hybrid modeling framework combining biophysics and deep learning to predict and optimize peripheral neuromodulation outcomes in lower urinary tract disease

Project Summary
There is huge potential benefit for peripheral neuromodulation to treat lower urinary tract (LUT) dysfunction
through highly targeted interventions. But development and optimization of therapies have been slow, we
believe, because we lack the ability to predict the system level, functional response of the LUT to different types
and parameterizations of nerve stimulation. Without such an ability, the only recourse is to explore the vast space
of possible neuromodulation therapies in animal models, which is slow and expensive. The goal of this project
is to invent a predictive model that can assess orders of magnitude more parameterizations through computer
simulation, so we can then focus costly experimental efforts on the most promising computationally identified
candidates.
To achieve this, we will create a framework that unites two powerful modeling approaches: first-principal
biophysics models and data-driven deep learning. The biophysics models let us precisely and powerfully
represent all the physiology that we understand quantitatively in a way that is both generalizable and
understandable. The problem with only using this approach, however, are the many parts of the LUT that we do
not understand with this level of confidence and detail. We will insert deep neural networks into the model
structure to statistically approximate the less well-understood LUT physiology. We will integrate both approaches
together in a single unified hybrid model, and train (tune parameter weights) the entire hybrid model at once with
data from cystometry experiments. In this way, we retain the power of biophysics-based models while
simultaneously reducing the size (and therefore data requirements) of the neural networks that need to be
trained. The neural networks will also be constrained by our LUT physiology knowledge, because they are linked
directly with biophysics-based models during simulation and training. We call the framework biomechanistic
learning augmentation of deep differential equation representations, or BLADDER.
In this project we will first design and validate the BLADDER modeling framework using existing biophysics-
based models of LUT organs and training the neural network approximations on data from physiologically
nominal cystometry studies. We will then expand the hybrid model’s generalizability and robustness by
manipulating the biophysics-based models to allow us to train on data from a wide array of experimental contexts.
Finally, we will use the expanded-context model to make predictions about the contributing physiological factors
and optimal neuromodulation therapies for underactive bladder syndrome, a highly prevalent LUT dysfunction
without adequate treatment options. Our project goal is to develop and validate the BLADDER framework, then
use it to make clinically useful predictions for underactive bladder treatment. Our long term goals are to apply
the BLADDER approach to many LUT dysfunctions that could benefit from neuromodulation treatments, as well
as to other physiological systems.

Public health relevance
Narrative Highly targeted nerve stimulation could greatly benefit people with lower urinary tract disease by correcting the behavior of malfunctioning organs; however, the urinary tract has so many complex, interacting parts that tuning all the stimulation parameters accurately to get good therapy is very difficult. We propose a new framework for computationally modeling the lower urinary tract that combines mathematical models of known physiological principles with unknown complexities accounted for by artificial intelligence. Drawing on this framework, we can simulate the urinary tract, and innumerable possible nerve stimulations, to learn more about what goes wrong in urinary tract disease and discover the most promising therapies.